Novel Sample Introduction Methodologies for Molecular Rotational Resonance (MRR) Spectroscopy

BrightSpec Inc. NIH SBIR Application
Project Summary
Novel Sample Introduction Methodologies for Molecular Rotational Resonance (MRR) Spectroscopy
NIH SBIR Direct to Phase II
BrightSpec, Inc.
Project Summary
This project proposes to develop a new analyte sampling technique for Molecular Rotational
Resonance (MRR) spectrometers for the volatilization of solid phase analytes. The proposed
system, Laser Induced Acoustic Desorption (LIAD), will enable a large number of important
compounds to be accessible by MRR, enhancing our understanding in several important areas of
research and accelerating pharmaceutical development. The resulting expansion of sampling
range and corresponding utility of this valuable technique will greatly accelerate the adoption of
MRR in important areas of research and development.
MRR is a spectroscopic technique for unambiguous structure determination and quantitation of
small molecules, which has been used for decades in academic research laboratories, but only
recently commercialized after the recent achievement of several groundbreaking innovations.
MRR excels in structural and isomeric analysis, providing a detail of information like nuclear
magnetic resonance (NMR), but at a much lower cost and faster speed, with reduced method
development. Through working on a final piece of the puzzle, the development of new sampling
techniques, BrightSpec seeks to unlock the full analytical potential of this powerful analytical
technique to broaden its use throughout a range of applications, including metabolomics, drug
discovery, natural product analysis, and the monitoring of environmental pollutants.
BrightSpec has evaluated several sampling techniques for volatilization of solid samples and Laser
Induced Acoustic Desorption (LIAD) was determined to be uniquely suitable for incorporation
with MRR, as the sensitivity of results with these instruments can be adversely affected by the
presence of solvents. BrightSpec has evaluated several sampling techniques for volatilization of
solid samples and Laser Induced Acoustic Desorption (LIAD was determined to be uniquely
suitable for combination with MRR, as the sensitivity of results with these instruments can be
adversely affected by the presence of solvents. The project would be conducted by BrightSpec in
collaboration with Kenttämaa Labs at Purdue University, which has been developing the LIAD
technique for use with mass spectrometry for over 20 years and holds several LIAD-related
patents.
A proof-of-concept prototype LIAD-MRR instrument has been used to demonstrate the viability
of coupling the two techniques. This preliminary work has de-risked this proposed Phase II project,
which involves refinement of the prototype to develop a product with the necessary sensitivity,
speed, and ease-of-use to facilitate commercial adoption. The resulting product will then be tested
thoroughly on relevant samples in market areas where LIAD-MRR is expected to have the greatest
impact. Several prospective customer use cases and samples have already been identified.
Following this extensive evaluation, the product design will be refined for commercial launch at
or before the end of the grant period.

Public health relevance
BrightSpec Inc. NIH SBIR Application Project Narrative Novel Sample Introduction Methodologies for Molecular Rotational Resonance (MRR) Spectroscopy NIH SBIR Direct to Phase II BrightSpec, Inc. Project Narrative Small molecule analysis lies at the heart of basic research, and in particular pharmaceutical research, as the understanding and monitoring of biological systems through sensitive measurement of important compounds such as amino acids and sugars, drugs (and related metabolites), and potential toxins and impurities provide critical insight. The proposed project will significantly enhance the ability of researchers to identify and quantify small molecules by combining Laser-Induced Acoustic Desorption (LIAD) sample vaporization with Molecular Rotational Resonance (MRR) detection that is singularly selective to subtle changes in molecular structure. The resulting commercial LIAD-MRR instrument will dramatically expand the range of compounds accessible to this valuable technique with a sensitive, rapid, easy-to-use configuration, allowing researchers to learn more about their samples than currently possible with existing methods and improving the speed of new groundbreaking discoveries.